Admin Core

Project Title: Nebraska Center for Heart and Vascular Research
Project Summary: Administrative Core
The Administrative Core of the Nebraska Center for Heart and Vascular Research will oversee all aspects of
the Center, including support for programs and resources that will expand and promote heart and vascular
research. We will create the critical infrastructure to facilitate heart and vascular research efforts and maintain
active communication among members and advisors. The Administrative Core will implement a comprehensive
tracking and evaluation program for all activities and outcomes to determine extent of success in goal
completion. The Administrative Core will actively solicit feedback and coordinate action plans for improvements
to ensure the Center is effective in providing support to grow heart and vascular research. We will enable
investigators to enhance their research capabilities by providing training and mentoring to promising early
career investigators. We will implement Center-wide activities that include focus groups, an annual retreat, and
a research seminar series. The Administrative Core will provide organizational structure and programmatic
leadership for research collaboration, funding, education, and mentoring programs to ensure efficient goal
attainment for both the Center and its investigators. The Administrative Core will coordinate efforts to develop
faculty, including overseeing the research project program, pilot project program, the research core voucher
program, and other mentoring and education efforts. We will serve as a coordination center for bridging Center
members with the research cores, leveraging with other IDeA Programs, and integrating established University
of Nebraska system resources. Combined, these efforts will generate a vibrant research environment that
promotes heart and vascular researchers and research.

Public health relevance
PROJECT NARRATIVE: ADMINISTRATIVE CORE Not applicable